Effect of Oral Cimetidine in the Protoporphyrias (IND 153247 submitted 9/2/2020)

PROJECT SUMMARY/ABSTRACT
Erythropoietic protoporphyria (EPP) and X-linked protoporphyria (XLP) are a genetic defects of heme
biosynthesis that cause life-long, painful cutaneous sensitivity to light. EPP and XLP, collectively called the
protoporphyrias, result in the accumulation of the light-sensitive molecule protoporphyrin IX (PPIX) in
erythrocytes and secondarily in the plasma and the liver. In addition to photosensitivity, protoporphyria can also
result in anemia, gallstones, and chronic liver disease, and in 2-5% of cases it results in rapidly progressive
cholestatic liver failure that is fatal without liver transplantation. Because patients are sensitive to visible light
and not UV light, sunscreen is not effective in EPP. Afamelanotide, which increases cutaneous melanin, was
recently approved by the FDA for the prevention of photosensitivity in EPP. Additional therapies besides
afamelanotide are necessary because afamelanotide is does not change PPIX level and therefore does not
prevent the life-threatening complications of EPP. Cimetidine has gained attention as a possible treatment for
human porphyrias because of a potential off-target effect of inhibition of ALAS, the first enzyme of heme
biosynthesis. This inhibition was first described in vitro. Later case reports suggested that cimetidine was
beneficial for the treatment of acute intermittent porphyria and porphyria cutanea tarda. Subsequently, case
reports also described a potential effect in EPP. However, these reports are anecdotal and uncontrolled. Some
patients also had pre-existing hepatic damage from EPP, which complicates the observations of drug effects in
EPP. Communications in the porphyria community indicate that a large number of patients, including children,
have used cimetidine without oversight and without a systematic record of dosage or symptomatic
improvement. The considerable interest in the larger porphyria community to assess with care its possible
benefit as a treatment approach has therefore neither been addressed nor satisfied. Therefore, the objective of
this study is to determine the efficacy and safety of oral cimetidine administration in the protoporphyrias. The
study design is a multicenter, prospective, randomized, double-blind, placebo-controlled, crossover trial, and
efficacy will be based on protoporphyrin levels, photosensitivity, and quality of life questionnaires. If the results
are positive, this would be the first study providing quality evidence for an agent acting as a disease-modifying
therapy for protoporphyria.

Public health relevance
PROJECT NARRATIVE Erythropoietic protoporphyria (EPP) and X-linked protoporphyria (XLP) are a genetic defects of heme biosynthesis that cause life-long, painful cutaneous sensitivity to light. The objective of this study is to determine the efficacy and safety of oral cimetidine administration for treatment of the protoporphyrias. Efficacy will be based on protoporphyrin levels, photosensitivity, and quality of life questionnaires.